1/2 CSUF/UCI-CFCCC Cancer Health Disparities Research Program (CHERP)

CSUF/UCI-CFCCC Cancer Health Equity Research Partnership (CHERP)
Overall Component: Abstract
California State University, Fullerton (CSUF) is an institution serving underserved populations and
underrepresented students (ISUPS), and the University of California, Irvine Chao Family Comprehensive Cancer
Center (UCI-CFCCC) is an NCI-designated comprehensive cancer center. Together, we plan to establish a
collaborative partnership to develop pilot research projects between faculty members at CSUF and UCI-CFCCC
that will generate preliminary data for R01 or other competitively funded grant applications, and educate
undergraduates (at CSUF) and master's students (at CSUF and UCI) in cancer health disparities research. The
Partnership plans to fund five pilot projects, and educate a total of 38 students during the length of the proposed
grant period. The overall specific aims of this new cancer-specific partnership are to: plan, implement and
evaluate a highly integrated and interactive cancer health disparities partnership between CSUF and UCI-
CFCCC; conduct pilot cancer health disparities research projects involving at least one investigator at each
institution that advance knowledge regarding cancer health disparities, leading to the submission of competitive
grant applications by NIH/NCI and other federal/non-federal agencies; and provide cancer research education
to underrepresented undergraduate and graduate students to increase their understanding of cancer health
disparities, leading to a larger pool of highly talented future scientists from diverse backgrounds.
To accomplish this we will undertake a set of activities organized under four components. The Administrative
Core will be responsible for the overall administrative and fiscal aspects of all P20 activities, and will include the
Executive Committee and Internal Advisory Committee. Activities will be implemented in three stages: initial
planning, implementation, and evaluation. The evaluation effort will be spearheaded by an external evaluator
with expertise in multi-component center reviews. The two pilot research projects each focus on a cancer health
disparity: the first is a basic science study that will conduct lipidomic profiling, and DNA and RNA sequencing of
tumor/NAT paired samples to optimize sample preparation and detect genetic/genomic and transcriptomic
differences that are related to African American triple negative breast cancer risk. The second is an
epidemiological study that will examine Asian sub-ethnic group differences in ovarian cancer mortality and
treatment patterns. The long term goals of this collaborative partnership are to diversity the cancer research
workforce and ultimately increase our scientific impact to address the cancer health disparity needs in Orange
County, California.

Public health relevance
CSUF/UCI-CFCCC Cancer Health Equity Research Partnership (CHERP) Overall Component: Narrative This proposed P20 partnership will contribute to the enhancement of cancer health equity research in Orange County, California through the development of institutional capacities, support of meritorious joint cancer research pilot projects, and the provision of cancer research experiences and programs for underrepresented students. The long term goal is to increase the diversity of the cancer research workforce at both partnering institutions, and increase the number of investigators conducting cancer health equity research.